Adaptive Testing of Cognitive Function based on multi-dimensionalItem Response Theory

Project Abstract
With the aging of the American population, the number of older adults at risk for developing cognitive impairment
is staggering. Recent research points to age-related change in cognitive performance beginning as early as age
30, highlighting the potential for early interventions. Cognitive function has long been assessed using
standardized cognitive tasks administered via neuropsychological evaluation. However, the traditional way to
assess cognitive ability is time consuming, requires trained personnel, requires an office visit, and identifying
decline among younger adults is particularly challenging because it can be masked by item redundancy effects.
Here we propose developing a new computerized adaptive test (CAT) to assess cognitive function, either in
clinic or remotely, that is based on recent advances in multidimensional item response theory (MIRT). We are
calling it the CAT-COG. The CAT-COG will assess global cognitive ability as a primary domain as well as 5
cognitive subdomains: episodic memory, language/semantic memory, processing speed, attentional
control/working memory, flexible cognition/reasoning. Our approach will revolutionize computer-based cognitive
testing (ultimately in a platform independent way), providing precise estimation of an individual’s ability on these
domains with minimal respondent burden, using a sufficiently large bank of items so that the same individual’s
cognitive ability can be assessed repeatedly without reusing items or stimuli. This project brings together an
accomplished interdisciplinary team of researchers and also builds on the unique resources of the Rush
Alzheimer’s Disease Center (RADC). These are the key project steps: (1) We will develop a new 500 item bank
of cognitive tasks and test them alongside a standard battery of neuropsychological tests through the RADC,
and in an online Prolific sample that includes younger adults. (2) Based on these data, we will develop a
computerized adaptive test (CAT- COG) appropriate for measuring global cognitive function and cognitive
subdomains across the life course. (3) We will test and validate the CAT-COG among returning RADC
participants who will also receive traditional neuropsychological testing. (4) We will study short-term variability of
the CAT-COG based on daily assessment for a week to determine learning effects and develop a testing
protocol that is immune to such effects. (5) we will harmonize the CAT-COG with the RADC standard battery of
neuropsychological tests so that existing data can be linked to newly collected CAT-COG assessments.

Public health relevance
Project Narrative This project aims to build the first computerized adaptive test based on multidimensional item response theory to more precisely, rapidly, and repeatedly assesses cognitive abilities, compared to existing gold-standard in- person neuropsychological testing. This assessment will be suitable across the adult lifespan (from cognitively normal younger adults to older adults with MCI), thereby advancing early detection of cognitive decline associated with Alzheimer’s disease. It also would be available online, thereby increasing accessibility in underserved populations and providing a new tool for basic and applied research.